IGF::OT::IGF REPLACEMENT OF THE ANIMAL FACILITY COLONY MANAGEMENT SYSTEM, YT 17-064

? The background: o Acquisition and installation of Topaz Elements software system to be used by FNLCR and NCI personnel to facilitate the tracking and maintenance of animal inventory, breeding, and health status. In brief, the system shall: • Track and maintain specific regulatory requirements (IACUC Tracking). • Track all aspects of rodent research and breeding colonies. • Have automated, multi-species animal inventory management and census reporting for animals, cages, and isolators for billing and cost accounting. • Have functionality for animal health monitoring and veterinary assessments for rodents and nonhuman primates. • Provide online access and reporting to intramural investigators and other FNLCR stakeholders. • Comply with Federal, HHS, NIH and NCI at Frederick IT Security regulations and policies.